Synthetic manipulation of engineered perivascular niches

ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
23-045. Glioblastoma (GBM) is the most common and lethal form of brain cancer. Standard of care is surgical
resection followed by treatment with the alkylating agent temozolomide (TMZ) and radiotherapy. Resection
removes the tumor bulk, and TMZ provides some benefit to many patients. The parent Cancer Tissue
Engineering Collaborative project (R01 CA256481) is developing a tissue engineering approach to accelerate
the evaluation of new anticancer compounds that overcome TMZ resistance. We are developing tissue
engineered models of the perivascular niches (PVNs) that extend from the tumor into the surrounding
parenchyma and which are believed to play a dominant role in invasion, recurrence, TMZ resistance, and poor
survival. Our efforts focus on developing an engineered PVN biomaterial, investigating pathophysiological
processes driving GBM invasion and TMZ resistance, and accelerating evaluation of novel TMZ derivatives
that target GBM regardless of MGMT status. The objective of this NOT-CA-23-045 NOSI Administrative
Supplement is to support a new collaborative initiative to incorporate synthetic gene circuits into our
engineered PVN models. Current tissue engineering brain vascular models lack orthogonal, regulatable control
over the growth and maturation of the perivascular niche. The ability to enact independent, quantitative control
over PVN growth and maturation would represent a significant advance and would enable us to deeply
examine reciprocal interactions within the PVN that may yield novel therapeutic targets to improve outcomes.
To realize this objective, we propose a new collaborative effort to with Dr. Ahmad Khalil (Boston University) to
apply his laboratory’s genome-orthogonal synthetic zinc finger transcriptional regulator (synZiFTR) technology
to enable drug-regulated, orthogonal control over PVN growth vs. maturation in the perivascular niche models
under development by this project. To do this, we will regulate growth and maturation of a synthetic engineered
perivascular niche (Aim S1). We will subsequently benchmark patterns of TMZ resistance and invasion in
response to synthetic vasculature (Aim S2). This proposed supplement will support a collaborative team to
develop a new yet complementary capability to integrate advanced tissue engineering and synthetic biology
toolsets to provide regulatable control over brain perivascular niche models. Collaboratively, we will establish
human synthetic tissue constructs as an important new tool to investigate reciprocal GBM-PVN signaling within
the brain tumor microenvironment. Such capabilities are essential for investigating patterns of GBM cell drug
resistance, invasion, and vascular remodeling necessary for improving patient outcomes.

Public health relevance
NARRATIVE Glioblastoma is the most aggressive and deadly form of brain cancer whose poor clinical outcome stems from its diffuse invasion throughout the brain and drug resistance. This project will develop a platform for synthetic manipulation of engineered perivascular niches to investigate glioblastoma cell proliferation, invasion, and drug response.